Efficacy, safety, and mechanisms of brain penetrable erythropoietin in Alzheimer’s disease mouse models

Project Summary/Abstract
Our application aims to develop a blood-brain barrier (BBB) penetrating erythropoietin (EPO) as a therapeutic
for Alzheimer’s disease (AD) and continues to pursue our long-term goal to develop BBB-penetrable biologics
for central nervous system (CNS) diseases, especially for AD. The rationale to develop EPO as a therapeutic
for AD lies in its ability to modulate several pathways implicated in AD pathogenesis, and its neuroprotective and
neuroregenerative effects. Such a strategy can delay or prevent new brain damage from occurring and potentially
reverse neuronal damage and cognitive decline; anti-Aβ antibodies do not offer such neurotrophic effects. The
main obstacles to the clinical translation of EPO for AD are limited BBB penetration and undesired hematopoiesis
with chronic high EPO doses. For this, we have used a clinically validated BBB drug delivery approach and fused
EPO with a monoclonal antibody (MAb) against the mouse transferrin receptor (TfR) which enters the brain via
BBB TfR-mediated transcytosis and is also rapidly cleared from the systemic circulation owing to the peripheral
TfRs; the latter is expected to minimize hematopoietic side-effects. Our exciting data shows that TfRMAb-EPO
is therapeutic in both a mouse model of amyloidosis and tauopathy. Our proof-of-concept work also shows that
TfRMAb-EPO indeed offers better therapeutic and hematologic indices than EPO in AD mice, however, there
are fundamental questions pertaining to the dose-response, therapeutic-time window, and the safety of TfRMAb-
EPO, that still remain unanswered. Further, a comprehensive investigation of the molecular pathways modulated
by TfRMAb-EPO in the AD brain has not been performed. Based on this, we hypothesize that TfRMAb-EPO is
a disease-modifying therapeutic for AD with better therapeutic and hematologic indices than EPO following
chronic dosing. Therefore, to advance the preclinical development of TfRMAb-EPO for AD, the following specific
aims will be pursued: Aim 1 will determine the efficacy of TfRMAb-EPO in dose-escalation studies, Aim 2 will
examine the safety of TfRMAb-EPO in dose-escalation studies, and Aim 3 will elucidate the molecular pathways
involved in the therapeutic effects of TfRMAb-EPO. We will perform dose-escalation studies in three AD-relevant
mouse models: amyloid precursor protein (APP) overexpressing Aβ mice (APP/PS1), in mice that combine tau
and Aβ pathology (3xTg), and in APPSAA knock-in mice that model AD without APP overexpression. The effect
on key AD pathogenic events (Aβ and tau, microgliosis, neuronal loss, and behavioral deficits), along with an
investigation of TfRMAb-, EPO-, biopharmaceutical- and AD-related adverse events will be studied in young and
aged AD mice. Finally, to gain insights into the molecular pathways modulated by TfRMAb-EPO in the AD brain,
spatial proteomics will be performed. Therefore, Aims 1 and 2 will establish the therapeutic range and time
window of TfRMAb-EPO while Aim 3 will provide mechanistic insights. Overall, the proposal, backed by a strong
scientific premise and data, will provide a clinically feasible and safe approach for sustainable EPO delivery to
the AD brain by utilizing state-of-the-art techniques and mouse models.

Public health relevance
Project Narrative Erythropoietin (EPO) is a potential treatment for Alzheimer’s disease (AD), however does not cross the blood- brain barrier (BBB), and therefore requires large doses which result in adverse effects. EPO has been modified to enter the brain by binding to the BBB transferrin receptors, and using this approach, EPO can be ferried into the brain non-invasively without the need for high doses. Our recent work shows that this BBB-penetrating EPO is protective in mouse models of AD, and the goal of this proposal is to evaluate the efficacy, safety, and mechanisms of the BBB-penetrating EPO at escalating doses in mouse models of AD.